Sources and consequences of individual differences in human functional brain networks related to controlled behavior

0'#!!12!!!34!!5!.68!(!9%-&,'!),#*1+!!!!!!!#$!!,!!,#$#-!!!#!!!*!!/-$-!!!1!,234!56!79:!6;!:,$-1,!!3!<#!,*!=,!#?!-$!!!,!!$@#,!!!!#%!!#*!A,!!*!0>&!--#!!!! S!,IBB!!!#,!!#!U!-!!-$-!,)##!!-,!!,,*!!'!!S-!.!#$!!!,#T!*F!!#,#!,G!$!!2,!!,*!!E#+#!!!!2!%D!&!4'E!!,-!,,!-!,!!(N!-;O$$!!R!!B)!!#J!!!K!2#6!.J!!4L!4!##L!-M!((N!!N#;!O;O--!Q!#P)!$!).##(,!-*!*!#-H!!!*!.C,#$!-!-!!!#!!#!!#*!!!'$-* ,!!G(U2)$!!!###E,!!L!,$#-!!!!#-#!$!!!$$!!-!,$B#!!!#!!*!#!#!(VT!!*!)!A*!!$A!$!!-#,!!,!!,$,S,!,!$,W![!\]X^Y!_!Y!`!,$2[!$Za$!X!#,*!6,KXZ!4,!B5M6!!B,(!T)!,!.!,#!!$!(-!!!!!!!!!!#(*W!!-!#)A#!,$!!.-(!B,!!!!-,,!!#!$,!-!!!$$-(!U,)!!!!,.b!#!!!c!.!!2!!!d))--

Public health relevance
Project Narrative Recent findings have demonstrated that individuals show specific, local differences in their brain network organization, locations we call "network variants"; however, the sources and consequences of these differences are not yet known. This proposal addresses these critical questions, testing the hypotheses that network variants are stable, heritable traits, and that they affect brain function and behavior. Thus, this proposal is relevant to (1) a basic scientific understanding of the links between individual differences in brain function and behavior, and {2) translational work that relies on measuring sources of individual differences in cognitive control that may be relevant to psychiatric disorders.